Neural basis of Braille literacy in blind adults and children

PROJECT SUMMARY
The proposed diversity supplement application is intended to support Ms. Zaida McClinton in her training as a
cognitive neuroscientist investigating brain plasticity. Ms. McClinton is a highly talented and well-trained
student completing her undergraduate degree in Neuroscience at Johns Hopkins University. The proposed
supplement will support her in obtaining a master’s in Neuroscience and conducting a year-and-a-half of
mentored research in my laboratory working on the neural basis of Braille reading in congenitally blind adults.
I will mentor Ms. McClinton while she designs, carries out, analyzes, presents and publishes this neuroscience
work on Braille reading. The grant will support her as she acquires critical skills in cognitive neuroscience,
including fMRI analysis and TMS, and give her the edge she needs to enter a high-quality MD-PhD program
and provide preliminary data for an NRSA F30 application. During the proposed supplement Ms. McClinton
will conduct a series of studies that build on and are complementary to the parent award but are not redundant
with it. Ms. McClinton will use the already collected fMRI data to conduct fMRI-guided TMS studies that test
the cognitive and behavioral contributions of the posterior parietal (PPC) and ventral occipito-temporal
(vOTC) cortical circuits to Braille reading. The goals of the parent award are to discover whether people who
are born blind develop ‘tactile word form’ representations in the PPC and to test the role of the vOTC in
Braille reading for blind adults and compare its contribution to that of the PPC. Ms. McClinton will first test
the behavioral relevance of the PPC and vOTC to reading using fMRI guided TMS, which has never been done
before. Next, she will test the timing of the contribution of these regions. We hypothesize that PPC performs
form-based orthographic processing, and is therefore involved earlier, whereas vOTC performs more high-
level language functions and is therefore involved later. These experiments are highly complementary to the
goals of the parent award, which will dissociate the contributions of these regions to Braille reading. Finally,
closing the loop and answering the question of why the vOTC is active during Braille reading, Ms. McClinton
will test whether vOTC is relevant to high-level linguistic processing in blindness. The proposed work is
highly theoretically significant and complementary to the parent proposal since TMS gives us an opportunity to
test behavioral relevance of activation observed with fMRI and to thus inform theories of Braille reading and
plasticity in blindness. We anticipate that the proposed experiments will lead to 3 or 4 first author publications
providing an intensive manuscript preparation experience. This opportunity will enable Ms. McClinton to
learn cutting edge cognitive neuroscience skills and propel her into a career as a cognitive physician-
neuroscientist investigating brain plasticity.

Public health relevance
PROJECT NARRATIVE The proposed research supplement to the parent grant, R01 EY033340, will support Ms. Zaida McClinton in an intensive three-year training program in the cognitive neuroscience of plasticity in Braille reading among congenitally blind adults, which is highly complementary and not redundant with my parent grant. Ms. McClinton will conduct fMRI-guided TMS studies to test the behavioral relevance and timing of PPC and vOTC cortical systems during Braille reading; specifically, during the first 18 months of this program Ms. McClinton will do the mentored research to obtain a master’s degree in Neuroscience from Johns Hopkins and during the last 18 months Ms. McClinton will conduct full-time mentored research. Ultimately, this intensive training will give Ms. McClinton the opportunity to publish 3 to 4 first author papers and gain critical skills and a strong scientific background, enabling her to enter a high-quality MD-PhD program and prepare to apply for an individual NRSA F30 grant.